Integrated Services for PWID using Person-centered Interactions, Reach, and Engagement (INSPIRE)

PROJECT SUMMARY
First-ever data from Zambia on people who inject drugs (PWID) demonstrates major gaps in the HIV
epidemic response. A recent biobehavioral survey show sharp health disparities along the entire PWID HIV
care continuum, with gaps in HIV testing, linkage to ART, and viral suppression, and limited knowledge of
PrEP. Failing to detect early HIV infections and address unsuppressed viral load poses a risk of ongoing
community transmission as well as increased risk for HIV comorbidities and mortality, threatening the overall
HIV epidemic control response in Zambia. The Zambia Ministry of Health has adopted a harm reduction
approach to address the health disparities experienced by PWID. Starting in November 2024, the Zambia
Ministry of Health will provide Medications for Opioid Use Disorder (MOUD) at two health facilities which also
provide HIV services. There is currently minimal evidence in sub-Saharan Africa on MOUD integration with HIV
care. The arrival of MOUD in Zamvia presents an exceptional opportunity to collaborate with Ministry of Health
and key partners to develop a person-centered integrated collaborative care model for PWID and pilot testing
implementation, feasibility, and preliminary effectiveness within the Zambian health system.
We propose the Integrated Services for PWID using Person-centered Interactions, Reach, and
Engagement (INSPIRE) study to co-adapt and evaluate an HIV status-neutral system-level integrated
approach using a Collaborative Care Management Model (CoCM) for HIV prevention, HIV care, mental health,
and MOUD. This implementation science study includes the following Aims: Aim 1: Assess the multilevel
determinants of early implementation of MOUD services using rapid qualitative analysis. Aim 2: Co-adapt an
HIV status-neutral CoCM with key stakeholders. Aim 3: Implement and evaluate the co-adapted CoCM, guided
by Practical, Robust Implementation and Sustainability Model (PRISM), and including the Reach,
Effectiveness, Adoption, Implementation, and Maintenance (RE-AIM) outcomes.
The research team, led by Multiple Principal Investigators (MPI), has expertise in psychiatry, HIV
clinical care, implementation science, behavioral and social sciences, HIV clinical care, epidemiology, and
mixed methods, and has a deep knowledge of HIV response and service delivery models in Zambia for
marginalized populations, and experience implementing opioid use treatment both in the US, and in Kenya. We
will also leverage the University of Maryland Baltimore’s decade of experience implementing MOUD and HIV
programs in Kenya. Addressing the unmet needs of PWID is urgently needed to achieve and maintain HIV
epidemic control; our findings will inform the implementation of integrated care models for PWID. Lessons
learned from INSPIRE will help develop best practices for system-level approaches to improve OUD treatment
and HIV prevention and treatment programs in both sub-Saharan Africa and the US.

Public health relevance
PROJECT NARRATIVE The INSPIRE study will co-adapt, implement, and evaluate an HIV status-neutral system-level integrated care approach using a Collaborative Care Management Model for Opioid Use Disorder and HIV prevention and treatment among people who inject drugs in Zambia.